Liposome fusion enabled extracellular vesicle detection for COVID-19

Abstract
COVID-19 can cause pathological changes that persist long after the resolution of the initial SARS-CoV-2
infection. New, more sensitive detection approaches are needed to better understand the potential mechanisms
involved in this process and to improve the detection of both symptomatic and asymptomatic COVID-19 cases,
including long-term infections, that may be missed by due to the significant false negative rate of the gold-
standard COVID-19 test, reverse transcriptase quantitative polymerase chain reaction (RT-qPCR). Respiratory
samples appear to be a poor choice to detect and monitor SARS-CoV-2 infections beyond a relatively narrow
window after virus exposure, as there is transient and intermittent viral production in the upper respiratory tract
after infection. Evidence indicates that SARS-CoV-2 may spread systemically through the circulation, suggesting
that blood, which is homogeneous and routinely collected with minimal discomfort and exposure risk, could serve
as an alternate diagnostic and monitoring specimen. RT-qPCR, however, exhibits poor diagnostic sensitivity for
COVID-19 when analyzing blood samples. Our team has developed a rapid, ultrasensitive COVID-19 assay
(CRISPR-FDS) where CRISPR activity cleaves a quenched probe in proportion to an amplified DNA target to
increase assay sensitivity 20-fold. This assay, now used as an investigational test, can detect COVID-19 cases
missed by repeated RT-qPCR testing of nasopharyngeal swab samples, and does not require expensive
equipment, significant technical expertise, or protective equipment. Our recent preliminary data suggest that
detection of circulating cell-free viral RNA by a CRISPR-FDS assay that analyzes isolated plasma RNA can
diagnose COVID-19 cases regardless of infection site(s) or duration. We therefore propose to adapt our
CRISPR-FDS method to allow direct quantification of viral RNA in plasma. In this assay, extracellular vesicles
(EVs) captured directly from plasma are induced to fuse with synthetic liposomes loaded with CRISPR-FDS
assay reagents within a small volume to amplify and quantify target RNA efficiently, using a standard ELISA
workflow. We selected EVs for this assay, since these vesicles are abundantly secreted by infected cells and
preserve viral RNA within their lumen, and can be specifically captured from plasma/serum by antibodies
targeting their surface protein to reduce background from cell-free nucleic acid. Aim 1 will optimize CRISPR-
FDS assay procedures (e.g., EV capture, liposome packaging and fusion, and reagent titration steps) to
maximize reaction sensitivity, and evaluate how modification of the liposome surface with target-specific
antibodies influences assay performance. Aim 2 will evaluate the analytical performance of the optimized assay
versus RT-qPCR for plasma samples, conduct and analytical validation of the liposome assay, and employ this
assay for quantitative analysis of SARS-CoV-2 RNA in plasma EVs present in longitudinal plasma cohort direct
EV-mediated COVID-19 diagnosis using serum or plasma, and quantitatively evaluate dynamic changes in
SARS-CoV-2 RNA in longitudinal blood samples from a cohort of COVID-19 patients.

Public health relevance
Narrative COVID-19 diagnostic tests that detect viral RNA in the blood have several potential advantages over assays that analyze nasal swab or saliva samples; however, the current gold-standard COVID-19 assay (RT-qPCR) has poor sensitivity to detect viral RNA in blood. We have reported that our CRISPR-based COVID-19 assay has 20-fold greater sensitivity than RT-qPCR, and can diagnose cases it repeatedly misses, using multiple sample types. This proposal is designed to adapt our current ultrasensitive COVID-19 assay to a nanoparticle-based assay format that can directly detect viral RNA in blood using limited resources available at non-traditional testing sites, and to validate the performance of this assay using clinical samples.